EHS Summer Undergraduate Research Program (EHS-SURP)

by training faculty, who are all members of the NIEHS Center for Research on Environmental Disease. The Center provides the cohesive and focused infrastructure that supports the EHS-SURP and provides a strong basis in EHS research. Under the direction of members of the training faculty, SURP students will conduct bench research on a defined, small project, related to the ongoing investigations in their mentor's laboratory. Students will also participate in didactic and career development activities designed to promote and prepare students for entry into graduate and professional education programs leading to EHS careers. The SURP has been continuously supported by a NIEHS T35 training grant entitled: Short Term Training for Minority Students, since 1996. Programmatic evaluations demonstrate that the SURP has been an important contributor to the career development of the participating students and has influenced their decision and ability to pursue graduate training leading to careers in scientific research and/or medicine. Project Description Page 6